Biostatistics, Epidemiologic, and Bioinformatic Training in Environmental Health (BEBTEH)

PROJECT ABSTRACT
The goal of the BEBTEH training grant, "Biostatistics, Epidemiologic and Bioinformatic Training in
Environmental Health", is to develop pre- and postdoctoral trainees into successful independent scientists
who will advance quantitative and environmental health sciences, and improve health for future
generations. With 8 pre-doctoral and 4 post-doctoral trainee positions, BEBTEH plans to continue to train
biostatisticians and life scientists to develop and apply quantitative methods to the environmental health
sciences. Anchored in the outstanding University of Washington research environment, participating
departments include Environmental and Occupational Health Sciences, Biostatistics and Epidemiology.
BEBTEH offers two distinct pathways—population-based and laboratory-based. The laboratory-based
pathway focuses on the interpretation of modern genomic, microbiome, and other biologic data and how
they may be exploited to unravel the biological bases of diseases. The population-based pathway
emphasizes statistical methods in environmental epidemiology to elucidate the etiologies of
environmentally-related diseases. Both pathways incorporate data science training into a multidisciplinary,
collaborative, and interdisciplinary training environment that includes quantitative and applied training
objectives; involves each trainee in a project that leads to expertise in multiple disciplines necessary to
advance environmental health science research; and targets training activities to advance training goals.
This is enhanced by a dual mentorship program that encourages trainees to work with both quantitative
and life scientists. Under the leadership of Elizabeth A. (Lianne) Sheppard, PhD with support from Deputy
Director June Spector, MD MPH and input from an Advisory Committee, BEBTEH will recruit and nurture
trainees from diverse backgrounds in a first-class research environment. Innovations in this renewal
application include new data science training opportunities that encompass big data, data sharing, open
science, collaborative and reproducible research, and a complementary focus on an environmental health
science research experience. Building upon its strong history of success and track record since 2009, and
leveraging collaboration with NIEHS-funded research centers and sister agency funding, BEBTEH trainees
will be well-positioned to help NIEHS meet its strategic vision.

Public health relevance
PROJECT NARRATIVE The environmental health science needs a new generation of leaders who are highly trained in the art of quantitative reasoning and data science to help alleviate the adverse impact of environmental exposures on health. The proposed training program, BEBTEH, bridges the environmental health sciences with bioinformatics, biostatistics and data science in a unified structure within a first-class research environment. BEBTEH will support 8 predoctoral and 4 postdoctoral trainees to help realize NIEHS’ vision “to provide global leadership for innovative research that improves public health by preventing diseases and disability.”